Upstate KIDS Follow-Up Study

The Upstate KIDS Follow-Up study began contacting all participants in October 2015 for continuing the study in the this new follow-up phase. A data coordinating center (DCC) developed a new website for online data collection and data management. Clinic visits were completed in Fall 2019. At clinic visits participants had measurements made of anthropometry, body fat by bioelectrical impedance, lung inflammation, blood pressure, arterial stiffness by pulse wave velocity and collection of urine, blood and saliva. Laboratory measures were delayed due to the COVID-19 pandemic. Data cleaning and analyses are ongoing. DNA methylation differences were identified and published.